Impact of Menstruation on Chlamydial and Gonorrhea Infection

Abstract:
Although vast majority and in many regions of the world, the overwhelming majority of women and adolescent
girls experience periodic menstruation; how this immune-mediated tissue remodeling process compromises
cellular immunity generated against sexually transmitted pathogens, including Chlamydia trachomatis (C.
trachomatis) and Neisseria Gonorrhoeae (N. gonorrhoeae), is poorly understood. C. trachomatis and N.
gonorrhoeae are the causative agents of the most costly and common bacterial sexually transmitted infections
(STIs), with the highest incidence of C. trachomatis infections occurring in women and adolescent girls of
reproductive age. Genital infections by these STI pathogens can lead to severe health complications, including
congenital transmissions, ectopic pregnancies, infertility, and chronic pelvic pain. Moreover, these infections
increase the risk of acquiring more severe secondary infections, including human immunodeficiency virus type-
1 (HIV-1). Taken together, these facts emphasize the critical need for an effective vaccine to prevent infections
of the female reproductive tract (FRT). Memory T cells that become localized in the cervicovaginal and uterine
mucosa through a recent infection or from vaccination provide optimal immune protection against bacterial STI
pathogens, leading to more rapid bacterial clearance and reducing disease severity. Therefore, generating long-
lived resident memory T cells in the reproductive tract mucosa that will recognize and respond against C.
trachomatis and N. gonorrhoeae is a promising approach to strengthening immunity. Previous scientific research
investigations into understanding tissue-resident memory T cell durability demonstrate that local environmental
molecular signals can provide critical support that determines tissue-resident memory T cell development,
regionalization, and prolonged viability at sites such as the lung, skin, and gut. Yet, despite the fact that genital
chlamydial and gonorrheal reinfections in women are common and there is no available vaccine, we have a very
limited understanding of how the tissue remodeling events of menstruation alter the reproductive tract
environment to drive T cell immunity. Therefore, a major challenge for developing prophylactic strategies,
including vaccines that can prevent genital chlamydia infections, is to determine how to support long-lived and
durable tissue-resident memory T cells in the reproductive tract under menstrual cycle regulation. The goals of
our proposal are to acquire critical insights into the mechanism(s) by which menstruation regulates immune
protection and identify strategies that can support optimal memory T cell durability against chlamydial and
gonococcal infections in the reproductive tract throughout this process.

Public health relevance
NARRATIVE The menstrual cycle influences the risk of acquiring sexually transmitted infections (STIs) by pathogens, including Chlamydia trachomatis and Neisseria gonorrhoeae, although the underlying immune contributions are poorly defined. Here, we propose to use a mouse model of menstruation to investigate when and how the process of endometrial remodeling and repair drives spatiotemporal immune and metabolic changes within the female reproductive tract (FRT) mucosae, describe how these alterations shape infections and the development of immune memory, and test vaccination strategies to strengthen immune durability. Our overall objective is to identify promising biomedical intervention strategies that will strengthen immunity against genitourinary pathogens in women.